Exploring palmitoylation dynamics: impacts on Cadherin-Catenin adhesion and lipid metabolism in the progression of melanoma lung metastasis

Melanoma, a major cause of cancer deaths, often metastasizes to the lungs and other organs, leading to a low
five-year survival rate of 15-20% in advanced stages. The effective treatment of metastatic melanoma, including
in the lungs, remains a significant challenge. Therefore, research focusing on understanding and combating
pulmonary metastasis of melanoma is vital for improving diagnostics, treatment strategies, and overall patient
outcomes, while also providing broader insights into cancer metastasis mechanisms. Protein palmitoylation, a
reversible form of lipid modification, is essential for mediating dynamic cell-cell interactions by enhancing protein
hydrophobicity, membrane association, and functional specificity. This post-translational modification enables
the assembly of protein complexes and signaling platforms vital for cell adhesion and intercellular communication.
Despite its importance, the role of palmitoylation in human disease is significantly understudied. Here, we present
preliminary data to show the involvement of ZDHHC13, a palmitoyl-transferase, in metastatic dissemination and
the immune-modulatory microenvironment, as an underexplored class of potential therapeutic targets. We find
that ZDHHC13, suppresses metastatic dissemination by palmitoylation of CTNND1, leading to stabilization of E-
cadherin. Significantly, ZDHHC13 also reshapes the tumor immune microenvironment by suppressing
lysophosphatidylcholine (LPC) synthesis in melanoma cells, leading to inhibition of M2-like tumor-associated
macrophages (TAMs) that we show degrades E-cadherin via MMP12 expression. Consequently, ZDHHC13
activity suppresses tumor growth and metastasis in immunocompetent mice. Furthermore, ZDHHC13 signaling
is disrupted in NF1-mutated melanomas, suggesting a potential synergistic interaction between NF1 mutation
and ZDHHC13 signaling loss. Based on these findings, we hypothesize that ZDHHC13 inhibits melanoma
metastasis through a dual mechanism involving both cancer cell-intrinsic and immune-modulatory pathways
within the tumor microenvironment. We also propose that activation of ZDHHC13 signaling may represent a
novel therapeutic strategy for metastatic melanomas harboring NF1 mutations. Our research aims are designed
to validate these hypotheses by: (1) defining ZDHHC13's role in cadherin regulation and metastasis suppression;
(2) exploring ZDHHC13’s influence on immune responses in metastatic melanoma; and (3) assessing ZDHHC13
pathway activation as a therapeutic approach, especially for NF1-mutated tumors. Completion of this study will
illuminate new strategies for combating melanoma progression and metastasis, with broader implications for
cancer metastasis treatment.

Public health relevance
This research seeks to improve understanding of melanoma metastasis and identify new therapeutic strategies. By investigating the role of ZDHHC13 in modulating both cancer cell behavior and immune responses, this study aims to enhance treatment approaches, potentially leading to better outcomes for patients with metastatic melanoma, particularly those with NF1 mutations.